De Novo Assembly Tools: Research with Unbiased Engines - Renewal (DNA-TRUER)

Summary
This grant renewal proposal is about developing innovative new software that allow health
researchers to take advantage of new advances in DNA sequencing.
Over the last decade, technology advances have made DNA sequencing a routine and cost-
effective method in many fields of life sciences research. The dominant technology at the start
of our project generated millions of short sequences, consisting of 75-300 base pairs (the
“letters” that make up the DNA sequence). These short “reads” have to be assembled in the
right order to make sense of the data. Dr. Birol and his team are world leaders in genome
assembly, and the award-winning software they have developed (with support from their
existing NIH grant and other funding) has been used in diverse DNA sequencing projects,
including The Cancer Genome Atlas project.
Newer technologies are now available that generate information on much longer stretches of the
input DNA as long or linked reads. Long read platforms can sequence over 100,000 base pairs
per read, though with a relatively high error rate. Linked read platforms can associate multiple
reads over similar lengths, although the data contains many gaps. Still, when coupled with
bioinformatics tools that can leverage the rich information they provide, these new sequencing
platforms open new frontiers in health research.
Dr. Birol is seeking to extend his NIH funding support so that he and his team can be
maintained to continue developing specialized software that quickly, accurately, and efficiently
assemble and analyse long and linked sequence reads. These tools provide advanced
capabilities in a range of projects, such as tracking infectious disease outbreaks, using genetic
information to select the best drugs to treat an individual patient's cancer, and other
applications.
The new tools are being made available online free for other non-profit researchers to use in
their own sequencing projects, allowing teams around the world to make faster progress in
health research.

Public health relevance
Narrative (health relevance statement) DNA sequence analysis tools developed by Dr. Birol are used by health researchers in the US and around the world in projects that have furthered our understanding of many different types of disease. The new software tools his team develops are designed to match recent advances in DNA sequencing technology, and make genetic analysis accessible to a wide group of health research teams. While the new tools are particularly relevant to understanding how infectious diseases spread and how cancer develops, they also find applications in diverse aspects of health research.